RELATIONSHIP OF OBESITY, HYPERINSULINEMIA &LH TO POLYCYSTIC OVARY SYNDROME

The relationship between obesity, hyperandrogenism, LH levels and insulin resistance has not been clearly defined. This study will take advantage of a newly developed method of accurately diagnosing PCOS, the nafarelin test, to investigate this question in both obese and non-obese PCOS subjects, and non-PCOS subjects. Influences of body fat distribution will also be evaluated.